Medical Scientist National Research Service Award

PROJECT SUMMARY
The Medical Scientist Training Program (MSTP) is committed to training the next generation of scholars and
leaders in the biomedical sciences by providing students with access to the very best resources of the
University of Chicago. Chicago's distinctive interdisciplinary approach encourages students to explore their
medical and research interests in the broadest possible terms in medicine, biology, the social sciences and the
physical sciences. The University of Chicago was among the first schools to obtain MSTP federal funding.
Currently, we are in our 50th year and have graduated 290 physician scientists. Our trainees have made many
fundamental contributions to our understanding of biology and human disease resulting in numerous papers in
Nature, Science, Cell, and other high-impact journals. Our graduates have gone on to lead important
departments and academic units including the MSTPs at UCSF, Stanford, Harvard and Indiana. Four of our
trainees have been elected to the National Academy of Sciences. During the current training grant period
(2012-2016), we have graduated 33 students all of whom have published substantial bodies of work.
Remarkably, 13 of 16 of our current students (81%) have been successful in their F30 applications. This level
of accomplishment has been obtained while maintaining a time to graduation of 7.9 years and a five-year
attrition rate of 2.5%. By any metric, our program, trainees and graduates are successful. Currently 64
individuals, from all over the country, are enrolled in the program of which 50% are women and 22% are
URMs. We are a diverse and balanced national academic program of excellence. We are also a highly
competitive program with five-year average entering metrics of 3.81 GPA and 98% MCAT with a matriculation
rate of 2.1% from a five-year applicant pool of 2280. We are requesting that our current 22 slots be renewed.
This level of support, in conjunction with substantial and ongoing support from the University of Chicago
Biological Sciences Division, will ensure that at least 10% of the total incoming Pritzker Medical School Class
is trained as physician scientists. Relative to our institutional support, the requested NIH investment is
reasonable, constituting only 24% of our anticipated budget.

Public health relevance
PROJECT NARRATIVE The University of Chicago Medical Scientist Training Program (MSTP) is designed for students who wish to pursue broad careers in research relevant to human health and disease. Overall, the MSTP seeks to fulfill a national need for individuals who will apply clinical and research experience to biomedical investigation, is committed to training the next generation of scholars and leaders in the biomedical sciences by providing students with access to the very best resources of the University of Chicago, and will catalyze the application of multidisciplinary approaches to solve the most pressing problems in medical science. MSTP Chicago's distinctive interdisciplinary approach encourages students to explore their medical and research interests in the broadest possible terms in medicine, biology, and the physical sciences.